METABOLIC AND ENDOCRINE DEFICITS IN LEAN NONDIABETIC OFFSPRING OF IDDM PATIENTS

THis study is designed to examine prospective changes in the insulin sensitivity and insulin secretion in first degree relatives of non-insulin dependent diabetics compared with individuals with no family history of diabetes.